Developmental Research Program (DRP)

ABSTRACT
To enable SPORE investigators to rapidly develop new research opportunities which could translate into
early benefits for breast cancer patients, and to allow for exploration of new techniques which may require
substantial efforts but which are nevertheless not ready for full scale multi-year research funding, we have
devoted considerable effort and resources to this SPORE Developmental Research Program. The Executive
Committee, together with the advocate members and the Internal Advisory Board, selects proposals for funding
as Developmental Projects, based on their scientific merit and relevance to SPORE translational goals.
Through the funding of pilot projects, we broaden the scope of research, and allow exploration of high-risk
ideas that have the potential for high yields in treatment, prevention, or basic biology of breast cancer. We also
attract new investigators with a wide variety of special expertise to apply their expertise to problems and
questions in breast cancer research, and we catalyze productive collaborations in which individual skills and
approaches combine to create progress that no single investigator could achieve alone. It is important to point
out that, although only $50,000 per year is requested from SPORE funds for this program, and Baylor College
of Medicine is contributing an additional $50,000 per year in recognition of the value of this outreach effort to
cancer research at Baylor.
During the 26 years of funding since our first Breast SPORE award in 1992, we funded 106 developmental
projects, contributing to 128 publications and providing essential preliminary data for 85 successful grant
applications with several still pending. Two of the new full projects in this application derived in part from
developmental projects to Drs. Chang and Westbrook. This mechanism complements the larger and longer-
term regular research projects, offering a degree of flexibility which leads to enhanced productivity for the SPORE
as a whole.

Public health relevance
NARRATIVE For the fastest and most efficient progress against breast cancer, we need to draw the broadest possible range of ideas and approaches into the fight. SPORE developmental projects allow us to take on high risk research and attract new ideas, so that the most promising can earn support to become larger successful efforts either within the SPORE or with other major funding.